Administrative Core

The Administrative Core of the Center serves a straightforward function. First, it maintains active oversight of the scientific priorities and directions of the research through regular conference calls of the Pi's that serve as an Executive Committee. Second, the Core will be responsible for administering the day-to-day activities of the Center. This includes the appropriate disbursement and expenditure of funds for personnel, equipment, supplies, and miscellaneous expenses, according to the established budget. Oversight over preparation of progress reports, shipments between sites (including, reagents, mice, tissue samples, etc.).